Role of mitochondrial dynamics in rod photoreceptor cells

Abstract
Mitochondria, the energy generating organelles, dynamically fuse and fission to take various forms in
different cells. Mitochondrial dynamics have been linked to complex cellular processes such as metabolism,
immune response, and cell death, but the exact relations between their form and function are still not fully
understood. Retinal rod photoreceptor cells, the energy intensive neurons, provide an excellent model for
investigating the significance of mitochondrial form because they have a uniquely uniform arrangement of
elongated mitochondria in the inner segments and one large circular mitochondrion in each of the presynaptic
terminals. In our preliminary study, rod photoreceptor cell-specific ablation of mitochondrial fusion proteins,
mitofusin 1 (MFN1) and mitofusin 2 (MFN2), resulted in fragmentation of mitochondria by one month of age,
followed by extensive photoreceptor cell degeneration by the adult age. In addition, rod photoreceptor cell-
specific ablation of a mitochondrial fission factor, dynamin-related protein 1 (DRP1) caused late-onset and age-
dependent retinal degeneration (obvious by one year of age), suggesting the role of DRP1 in aging rod
photoreceptor cells. Therefore, we hypothesize that development and maintenance of the mitochondrial form
through mitochondrial dynamics are vital for sustaining rod photoreceptor cell health and function. In Aim 1 of
this proposal, we will test the hypothesis that mitochondrial fusion is critical for establishing rod photoreceptor
cell-specific mitochondrial structures and metabolic status during postnatal development. In Aim 2, we will test
the hypothesis that mitofusins maintain the health of rod photoreceptor cells by affecting the metabolic
pathways. In Aim 3, we will examine the role of the mitochondrial quality control mechanism through DRP1 in
aging rod photoreceptor cells. Successful completion of these studies will provide novel insights into the
functional significance of the regulation of mitochondrial dynamics in rod photoreceptor cells, downstream
effects of changes in the mitochondrial form, and the link between mitochondrial dynamics dysfunction and
neurodegeneration.

Public health relevance
Narrative While regulation of the shape and form of the energy generating organelles, mitochondria, through fission and fusion (mitochondrial dynamics) is linked to a variety of complex cellular processes, the exact relations between mitochondrial form and function are still not fully understood. In this study, we will examine the roles of mitochondrial dynamics in retinal rod photoreceptor cells that display unique shape and arrangement of mitochondria using mouse models. Successful completion of this study will provide novel insights into the relationship between mitochondrial form and function as well as the functional significance of mitochondrial dynamics in the retinal health, and may suggest novel therapeutic strategies for retinal conditions associated with mitochondrial abnormalities.